Targeted Delivery of Tumor Antigen esaRNA to the Spleen for Cancer Immunotherapy

Project Summary
This application is in response to Notice of Special Interest (NOSI) NOT-AI-24-007 (RNA Delivery Technologies to
Allow Speciflc Tissue Target Homing) to support the development of non-viral technologies to deliver RNA-based
therapeutics to disease-relevant cells and tissues in vivo. We propose an innovative strategy that combines
enhanced self-amplifying RNA (esaRNA) and spleen-targeting delivery nanomaterials to confer a therapeutic anti-
tumoral immune response. We have developed esaRNAs, which include an engineered flrst ORF (that normally only
encodes the alpha viral nonstructural proteins) that incorporates a constitutively active STING protein that is
expressed early but at low level in transfected cells in concert with the normal self-amplifying RNA replication
complex, leading to superior innate immune signaling without signiflcantly sacriflcing expression of the desired
encoded antigen. Tiba’s proprietary RNA encapsulation compounds are based on molecularly deflned,
biodegradable dendritic structures with ionizable amine moieties and terminal lipid extensions. This platform
generates highly compact and monodisperse nanoparticles with superior consistency in particle diameter and
stability than competing systems. The spleen is the largest secondary lymphoid organ and is a primary site of
action where antigens are presented to the immune system to initiate the deployment of effector lymphocytes
into circulation. Delivery to antigen presenting cells that are populous in the spleen has been previously
established to improve the immunogenicity of RNA-encoded antigens and can lead to improved tumor clearance.
This proposal will test the proposed platform in (i) a human papillomavirus (HPV)-based tumor model and (ii) a
melanoma model as a proving ground. The model antigens of interest (HPV16 E7 and Trp2) are selected for the
ease of preclinical testing in small animals and because of their clinical relevance in humans. The purpose of Aim
1 is to study Tiba’s existing panel of spleen-specific formulation candidates in terms of potency in desirable APC
subsets and undesirable inflammatory effects. The goal of Aim 2 is to validate the biological efficacy of the
lead RNABL spleen delivery formula in terms of adaptive cellular immune response against a model HPV tumor
antigen and protection in prophylactic and therapeutic modalities. Finally, Aim 3 will follow a similar experimental
design as Aim 2 using the B16 melanoma cell model. The conclusion of this project will set the stage for a Phase II
SBIR application to advance the platform through late preclinical development with the goal of establishing a pre-
IND package against a lead tumor-associated antigen target.

Public health relevance
Cancer immunotherapy has emerged as a promising approach as it enables noninvasive mobilization of the host’s immune system against tumors, and can be highly customized to the needs of a particular patient. In this Phase I SBIR application in response to Notice of Special Interest NOT-AI-24-007 (RNA Delivery Technologies to Allow Speciflc Tissue Target Homing), Tiba Biotech proposes to develop a novel tumor antigen immunization platform that combines a proprietary enhanced self-amplifying RNA (esaRNA) and spleen-targeting delivery technology to provide tissue speciflc, low inƲammatory cancer vaccination. The ultimate goal of this project is to produce an i.v. administered cancer immunotherapy that has less adverse effects than current treatments, elicits strong anti- tumoral immunogenicity, and successfully eradicates tumors.